Pharmacokinetics of sedatives – Understanding a modifiable risk factor for pediatric delirium

Project Summary/Abstract
Over the past decade, delirium – identified as an unexplained alteration in cognitive function as a result of
another clinical condition – has become recognized as a public health emergency for adults with critical
illnesses. In this patient population, delirium is associated with mortality, morbidity, increased length of hospital
stays and increased health care costs. We have developed a delirium screening tool to assess delirium in
children of all ages. This score, the Cornell Assessment of Pediatric Delirium, has been validated with several
psychiatrists at Cornell University and is starting to be used as a part of clinical care. While the development of
delirium is multifactorial, sedatives represent a modifiable risk factor for clinicians to consider. To date, there is
no pharmacokinetic information to guide clinicians on which sedatives are linked to delirium development.
Based on extensive preliminary evidence, we suspect that benzodiazepine-based sedation is related to
delirium development and may be affected by drug clearance and serum concentrations. We will also
determine if other commonly used narcotics and other agents are associated with delirium development
independent of benzodiazepine effects. We will test these two specific aims in a multi-centered (n = 3) study
with analysis done at the University of Pittsburgh and University of Buffalo.

Public health relevance
PROJECT NARRATIVE Delirium is recognized as a significant contributor to morbidity and mortality for critically ill adults and children. Based on strong preliminary data, this study proposes that benzodiazepines metabolism contributes to the development of delirium in critically-ill children. Moreover, we propose that other sedatives do not play a significant role in the development of pediatric delirium. As a modifiable risk factor, determining the pathophysiological role of benzodiazepines in delirium development can lead to marked improvements in patient care and outcomes in the future.